Vaccine and Treatment Evaluation Units: Clinical Trial for a Shigella Vaccine Candidate

This program is comprised of a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising products to combat infectious diseases.